Dynamics of activity-induced transcription in single dentate granule cells

Project Summary
In brain regions involved in learning and memory, a subset of neurons active in response to a novel experience
is critical for encoding and later recalling a memory of that experience. These neurons, known as engram cells,
have been identified as vital contributors to memory function in areas such as the hippocampus. Studies of
engram cells have overwhelmingly used immediate-early gene (IEG) protein products to segregate active from
inactive cells. Yet, the downstream processes that allow IEG-expressing cells to encode memories in a way that
makes them selective to a particular event remain unknown. Single-nuclei RNA-Seq (snRNA-Seq) now offers
an opportunity to reveal molecular changes in these engram cells at the single neuron level. Within the
hippocampus, individual, active, IEG-expressing dentate granule cells (DGCs) show more dramatic
transcriptional changes than other hippocampal cell types when mice explore a novel environment. Long after
IEGs such as Fos and Arc decline, transcription of later waves of activity-regulated genes continues to distinguish
active and inactive DGCs for at least 24hr after an initial stimulating event. While the hippocampus as a whole
is critical for memory function, the unique contribution of the dentate gyrus is theorized to be discriminating
between memories of similar events, a process termed pattern separation. This project will seek to link
transcriptional changes in individual dentate gyrus engram cells to the dentate gyrus’ role in pattern
separation. The underlying hypothesis is that activity-induced transcription sets the selectivity of DGC engram
cells and in turn the effectiveness of the dentate gyrus in discriminating between similar memories. A series of
experiments will compare activity-induced transcription and engram cell selectivity under standard cognitive
conditions, enhanced cognitive conditions, and impaired cognitive conditions. First, a candidate gene
upregulated in activated DGCs from previous snRNA-Seq results, proenkephalin (Penk), will be manipulated in
healthy adult mice. Penk has received considerable attention in studies of reward and addiction, and this project
will now test a novel role in influencing engram cell selectivity. Second, transcriptional changes in individual
DGCs in control mice will be compared those in runners, who have enhanced dentate gyrus function and ability
to discriminate similar memories. Finally, transcriptional changes in individual DGCs will be compared between
wildtype mice and APP/PS1 mice, a model of Alzheimer’s Disease with impaired discrimination ability. The
experiments described here will identify detailed transcriptional signatures of individual dentate gyrus engram
cells during memory formation and connect these molecular changes to the dentate gyrus’ critical role in pattern
separation. The results obtained from this work will reveal fundamental biological processes that can be targeted
to enhance cognitive function in health and combat devastating memory decline in neurodegenerative disease.

Public health relevance
Project Narrative To navigate daily life, novel experiences must constantly be compared to prior experiences to determine whether prior information is still accurate or if conditions have changed. This project will link novel-experience- induced changes in individual neurons of the dentate gyrus, which is critical for distinguishing between similar experiences, to physiological states in which memory function is enhanced or impaired. Understanding the link between gene expression in individual cells and memory function will reveal novel targets for maintaining healthy memory and restoring function in aging and disease.